MULTIDOSE, DOUBLE BLIND CLINICAL TRIAL OF SAFETY AND EFFICACY OF ENOXAPRIN

The objective of this study is to assess the safety and efficacy of a low molecular weight derivative of heparin in subjects undergoing elective total hip replace replacement.